Understanding the mechanisms of intracellular filamentation by bacteria

PROJECT SUMMARY
Bacteria often change their cell shape as a fitness strategy to survive or thrive in diverse environments.
Filamentation is one such morphological strategy, whereby a bacterium dramatically increases in cell size as
it undergoes longitudinal growth without septation. Many bacteria have been observed to undergo
filamentation, but the purpose of these filaments in a host animal is often unknown and the genetic
mechanisms governing this morphological change are largely understudied, outside of the canonical SOS
response. This proposal utilizes an innovative model system to study bacterial filamentation in the context of
a host animal, which consists of a facultative intracellular bacterium, Bordetella atropi, that filaments in the
genetic model organisms Oscheius tipulae and Caenorhabditis elegans. Strikingly, B. atropi uses
filamentation as an adaptive response to nutrients for cell-to-cell spreading: after invasion of an intestinal
epithelial cell, B. atropi converts from a coccobacillus to a filamentous morphology and these filaments invade
multiple neighboring epithelial cells. This filamentation by B. atropi was found to be independent of the
canonical SOS response but required a conserved nutrient-sensing pathway, the glucolipid pathway, which
produces and utilizes the bacterial metabolite UDP-glucose. Divergent bacteria use the glucolipid pathway to
detect rich culture conditions and delay the divisome resulting in moderately larger progeny after binary
division. Taken together, these discoveries suggest that B. atropi detects the rich intracellular environment of
its host cell to trigger filamentation, allowing it to invade neighboring cells. This proposal will further elucidate
the mechanism that the glucolipid pathway uses to inhibit the bacterial divisome and initiate filamentation,
uncover the role that host metabolites play in triggering the phenotype, and discover other genes/pathways
controlling intracellular filamentation by bacteria. First, the genetic mechanism that glucolipid pathway
members use to constitutively inhibit septation will be investigated in B. atropi and this pathway will be tested
in related bacterial species for a role in controlling filamentation. Second, given that the glucolipid pathway
can delay binary division in bacteria grown on rich media, B. atropi will be tested for dependency on host
glucose levels and a rich intracellular environment to induce filamentation. Finally, a transposon mutagenesis
screen will identify a majority of bacterial genes required for intracellular filamentation in O. tipulae. The
results established here will serve as a technical roadmap for determining whether other bacteria can use the
glucolipid pathway or other novel genetic pathways to induce filamentation. Given the importance of
filamentation to bacterial function and survival in a variety of niches, including in the context of a host animal,
this work will increase our understanding of both the environmental triggers and genetic mechanisms that
lead this vital morphological change.

Public health relevance
PROJECT NARRATIVE Morphological plasticity is fundamental to bacterial fitness and survival in a variety of environmental and host- associated niches. Filamentation is an example of this plasticity, as bacteria can dramatically increase in length to survive a variety of insults, including predation, phagocytosis, and exposure to antimicrobial compounds. This proposal will characterize a novel, nutrient-based mechanism for induction of filamentation whereby an intracellular bacterium detects invasion of a host cell to initiate filamentation for spreading into neighboring cells.